Visualization software for genomics

To gain maximum benefit from big data in genomics, biologists need software tools that enhance our in-
born cognitive and visual faculties. Our visual and cognitive systems possess extraordinary power to
recognize patterns, and visual analytics software applications aim to enhance this ability by providing
visual, interactive interfaces to data. My research focuses on developing visual analytics tools and
associated resources for life scientists, using Integrated Genome Browser as a platform for delivery and
experimentation. Integrated Genome Browser is a fast, highly customizable, freely available open source
desktop genome browser application developed since the early 2000s that now serves thousands of
users worldwide. By developing and supporting IGB for its thousands of users, my research contributes
innovative new approaches for genome browsing that other visualization research programs can and do
build upon. During the next five years, I will continue using state-of-the-art open source software
development methods adapted to an academic setting to build and release advanced tools at low cost,
while training students in computer science and bioinformatics. First, I will continue to develop new ways
to exploit emerging public and private cloud infrastructure to meet biologists’ increasingly complex needs
for advanced visual analytics. Using commercial and free-of-charge, public sector cloud platforms, my
students and I will experiment with connecting Integrated Genome Browser to storage and visual
analytics computing capability exceeding what is possible to achieve on a single, desktop computer.
These advanced features within IGB will help move the entire field forward by demonstrating how
application developers can harness the power of the cloud for visualizing data. Second, I will continue to
build IGB and related tools into a platform that other developers can exploit and learn from. The field of
genomics changes rapidly. As new methods and tools come on-line, developers need ways to create
new visualization tools suited to these new methods. My research aims to provide a platform for
experimentation that will enable developers in bioinformatics to build and release new visual analytics
algorithms more rapidly to larger numbers of potential users. My group will continue to develop and
support an App Store for IGB, an on-line clearinghouse for developers to distribute Apps and for users to
find and install Apps relevant to their research. To support developers, we will continue to improve IGB’s
internal application programmer’s interface (API), a collection of methods and classes crafted to enable
developers of varying skill and knowledge to add new functions and features to the IGB interface. Third,
my students and I will continue to explore larger concepts of community, open source software
development, and humane software design by connecting tool builders with tool users to promote
collaboration and innovation for the benefit of all.

Public health relevance
Continued progress in the life sciences depends on researchers having access to powerful visualization software tools that make it easy for them to discover and visually analyze novel patterns and trends in data. My research investigates methods for creating such software, focusing on building tools to visually analyze data from large- scale genomics assays used in research and clinical settings. My program trains students in advanced, state-of-the-art software development methods while creating open source genome visualization software that is freely available for everyone to use.